Harnessing simulations to uncover molecular mechanisms of mechanosensing

Project Summary
Mechanical forces play a fundamental role in the behavior of many proteins within cells. Specific
proteins have evolved to sense and alter their behavior in response to a stretching or compressive
stress. This can happen in environments that are naturally under tension, such as cellular membranes,
or in environments that are constantly rearranging due to active forces generated by molecular motors.
In such environments, there is a close coupling between macroscopic forces at the level of entire
cellular systems, and how those forces are sensed and generated by individual macromolecules.
Predicting how these systems interoperate using computational techniques remains a challenge due to
the need to span a wide range of length and time scales. Moreover, at the molecular level, the
mechanical forces involved are quite small, and hence it is difficult to predict how proteins undergo
significant changes to their conformational ensemble in response to these tiny perturbations. In our
group, we have pioneered approaches to overcome this challenge, resulting in new computational
methods that allow us to robustly predict both changes in conformational ensembles under tension as
well as the force-dependence of unbinding rates using atomistic molecular dynamics simulations. We
have also worked to make all our methodological advances available as open-source software tools.
Currently, we are combining these new approaches to tackle mechanosensing problems of
unprecedented complexity. We also work closely with experimental collaborators, including through
joint mentees, and that work inspires our future to study load-bearing structures in both mammalian and
bacterial systems. In this proposal, we describe planned efforts to extend our approaches to large
biomolecular complexes and proteins in complex cellular environments such as bacterial membranes,
which will necessitate further advances in simulation and machine learning approaches to treat these
assemblies. Our studies will result in new and improved tools and techniques to share with the
community, as well as insight into the functioning of crucial mechanosensitive motifs in living systems.
Ultimately, our aim is to connect molecular responses to force to with emergent large scale mechanical
properties of living systems.

Public health relevance
Project Narrative In our work, we are focused on how mechanical forces (pulling, pushing, stretching, and squeezing) impact the behavior of proteins in living systems, and in particular how special proteins are designed to perform a particular function in response. We use and develop computational tools that let us understand these mechanosensitive processes at different length and time scales, so that we can bridge our understanding of how cells function at the macro level with how molecules interact at the atomic scale. Our methodological developments and investigations of the fundamental role of mechanical forces in biology will lead to new understandings of cellular behavior, including in disease relevant contexts such as the interaction of cancer cells or virulent bacteria with their environment.